Health Promotion and Disease Prevention Research Centers

People with epilepsy (PWE) face many problems including complicated medication regimens, lifestyle
adjustments, management of symptoms, stigma, emotional difficulties, co-morbid depression, cognitive
struggles, disability, under- or unemployment, and limited access to transportation. Epilepsy self-management
can improve treatment outcomes and overall quality of life for PWE. Project UPLIFT (Using Practice and
Learning to Increase Favorable Thoughts), a Managing Epilepsy Well (MEW) Network self-management
program is theory-based, can be distance-delivered, and has been shown to be effective in reducing symptoms
of co-morbid depression among PWE. However, adoption of such a program in communities that experience
the greatest negative effects of health disparities has been slow. Black or African Americans, who constitute
about a third of the population of Georgia, carry a heavier burden with regard to epilepsy compared to their
White counterparts, and the efficacy of Project UPLIFT among Black adults is only now being investigated.
The current proposed project will replicate and evaluate the efficacy of Project UPLIFT with a sample of Black
adults with epilepsy and identify key facilitators and barriers to adoption among this population. Additionally,
as part of our dissemination plan and contributory role in the MEW Network, we propose to support the
continuation of the MEW Network integrated database (MEW DB) initiative that uses archival data to conduct
relevant secondary analyses to inform best practice in epilepsy self-management.
Using a community-engaged approach, our proposed activities are consistent with the SIP RFA's stated
project objectives to: (1) utilize findings from the literature and formative research to incorporate recommended
strategies for enhancing participant recruitment and retention throughout the study; (2) explore and evaluate
associations of patient-related factors (e.g., health literacy) to inform best practices for the epilepsy field; (3)
conduct a replication study of an existing evidenced-based MEW Network self-management program, Project
UPLIFT, in Blacks with epilepsy across Georgia; and (4) identify enabling factors and barriers to program
adoption, engagement and retention in evidence-based epilepsy self-management programs.
The proposed study will be conducted in three phases: (1) a formative phase, during which we will utilize
focus groups and in-depth interviews to identify strategies to improve recruitment and retention as well as
understand health literacy and epilepsy health knowledge for African Americans with epilepsy; (2) an
implementation phase, during which we propose to replicate and evaluate the efficacy of Project UPLIFT for
reducing symptoms of stress, anxiety, and depression, seizure frequency and quality of life among African
Americans; and (3) a dissemination phase, during which we will share our findings with community
stakeholders and scientific outlets, and we will share our data with the MEW Network database.

Public health relevance
The objectives of this project are to: 1) conduct formative research to explore recruitment and retention strategies and examine perceptions of epilepsy health knowledge and health literacy; 2) replicate the epilepsy self-management program, Project UPLIFT, and 3) evaluate and disseminate the efficacy of Project UPLIFT, among Blacks with epilepsy in Georgia.